Genome-wide identification and characterization of Alzheimer's Disease-associated enhancers

PROJECT SUMMARY/ABSTRACT
The sequencing of many tens of thousands of human genomes has revealed a plethora of sequence
differences or variants. Most variants appear to be of no or little functional consequence; however, a small
fraction of these variants can alter genome regulation and the susceptibility to and prognosis of particular
diseases. Our goal is to develop and use a general and efficient approach to identify and characterize
Alzheimer-Disease-associated Variants (ADaVs) that reside in powerful transcription regulatory elements
(TREs) called enhancers, which are distributed across vast non-coding regions of the genome and can map
considerable distances from the genes that they regulate. The TREs that contain ADaVs are called here
ADaV-TREs. Our unique approach relies on our recent demonstration that divergent transcription of enhancer
RNAs (eRNAs; most sensitively detected by our PRO-cap assay) is the best mark for precisely defining active
enhancers genome-wide (generally to 300 bp or less). We focus on identifying ADaV-TREs associated with
AD, the most common cause of dementia, using the exquisitely-controlled differentiation of an
induced-pluripotent stem cell line, WTC11, to generate highly homogeneous excitatory neurons and microglia,
two of the most relevant cell types in AD. In Aim 1, we use our PRO-cap assay to identify and delimit all TREs
in this pair of CNS cell types. These TREs that overlap ADaVs, either rare variants from Whole Genome
Sequencing or common variants from Genome Wide Association Studies, provide a highly enriched set of
variants that are likely relevant to genome regulation and a particular disease, i.e., AD. In Aim 2, we examine
enhancer activity of each ADaV-TRE by high-throughput eSTARR-seq assays relative to the reference (WT)
allele. Additionally, we will assay synthetic mutations in these TREs that target and cripple specific TF motifs,
and features of core promoter pairs that direct divergent enhancer RNA (eRNA) transcription, using
high-throughput mutagenesis and eSTARR-seq assays. In Aim 3, to characterize genome-wide effects of
those ADaV-TREs and synthetic mutations showing the most robust alteration in enhancer activity, we will use
CRISPR to introduce these perturbations at native loci into WTC11 cells and induce these to differentiate to
relevant CNS cell types. We will then characterize the effects of these perturbations using: 1) PRO-seq to
measure changes in genome-wide transcription at base-pair resolution; 2) chromatin conformation capture
(4C-seq) to examine changes in the 3D enhancer-promoter interaction profiles; 3) ChIP-qPCR to measure
alterations in transcription factor (TF) and co-activator binding; and 4) phenotypic assays to reveal disease
phenotypes. Our systematic and molecularly-precise analyses will identify TREs that are altered in their
regulatory activity and long-range interactions by variants, as well as the TFs and coactivators whose
association with TREs are affected. This information will be hypothesis-generating and critical for modeling
genome regulation and for dissecting molecular mechanisms of AD.

Public health relevance
PROJECT NARRATIVE Our genetic material, albeit being nearly identical from one person to another, is littered with many variations, some of which are associated with the development and progression of Alzheimer's Disease (AD). In this project, we are proposing a robust and economical approach that will enable identification and study of AD-associated genetic variations. The resulting data is expected to transform our mechanistic understanding of disease progression, and identify potential targets for therapeutic intervention.